CULTURAL EFFECTS ON RETENTION IN AUTOBIOGRAPHICAL MEMORY

The research focuses on the effects of culture on cognition, specifically the effects of change of culture (migration) on the distribution of memories across the lifespan. Subjects are bilingual/bicultural Puerto Ricans who have migrated permanently to anglo environments in the U.S. after growing up on Puerto Rico. Methods of cued recall will be used to test for: (1) a diminished fund of memories for events prior to migration, (2) differential access to memories according to cuing in the mother tongue or second language, and (3) a new concentration of memories ("reminiscence bump") corresponding to the development of a new identify as a result of migration. Content analysis of memories recorded by subjects will be used to test for memory vividness and to extract cultural and ethnopsychological themes.